The bone marrow extracellular matrix: scaffold of hematopoiesis

ABSTRACT
This proposal addresses the urgent need to understand disease mechanisms in Primary Myelofibrosis (PMF).
PMF is a disease with a dismal prognosis. The only potentially curative therapy, allogeneic stem cell
transplantation, is a high-risk procedure, with a mortality rate of at least 50%. Myelofibrosis is characterized by
excessive production of extracellular matrix (ECM), the fibers in bone marrow, which leads to a progressive
failure in blood cell production. A number of gene mutations, including JAK2V617F, have been reported in
PMF. While it is thought that hematopoietic cells carrying gene mutations abnormally proliferate and secrete
factors that stimulate stromal cells to produce ECM excessively, inhibition of JAK2 only partially improves
disease outcomes, and complementary therapies that specifically target ECM production are not currently
available. Dependence on the prevalent hypothesis, with its focus on gene mutations, is a critical barrier to
progress in the field. This project proposes instead to address the problem from the ECM angle. Building on
our published and preliminary studies with mouse and human samples, the central hypothesis of this proposal
is that abnormal activation of integrins (adhesive molecules that mediate cell attachment to ECM) facilitates
proliferation of PMF cells. As PMF proliferation arises from interaction between ECM and integrins, the
question is whether proliferation is triggered by an abnormality in ECM formation or by direct integrin activation.
Thus, I will explore two potential mechanisms behind this abnormal integrin activation, asking whether: (1)
abnormally high ECM production occurs in the vascular niche, where PMF cells develop, and (2) Lysyl oxidase
(LOX), an ECM enzyme upregulated in PMF, activates integrins in PMF through post-translational modification.
These studies will be performed on the most representative mouse model of human PMF, mice transgenic for
the JAK2V617F mutation. Effects of integrins on cell proliferation in PMF will be determined by blocking
integrin function with antibodies and by deleting integrin genes using CRISPR/Cas9. I will use 3D confocal
imaging and advanced computational analysis to determine the spatial distribution of cells, ECM, and
vasculature in myelofibrotic bone marrow, clarifying the mechanisms of ECM production by detailed
morphological analysis of the vascular niche. Proteomic analysis of post-translational modifications will be
performed on integrins to determine specific lysine residues oxidized by LOX, which has implications on the
development of therapies targeting integrins or LOX. This is a Career Development Award, and the PI of this
application will have the mentorship of investigators with expertise in the field for the execution of the project.
The project builds on previous experience of the PI in malignant hematology. The training and the expertise
acquired during this award will provide a foundation for a successful independent career for the PI of this
project.

Public health relevance
PROJECT NARRATIVE This project addresses the critical need to elucidate disease mechanisms of Primary Myelofibrosis (PMF), a disease characterized by excessive production of extracellular matrix (ECM) which inhibits production of blood cells in bone marrow. Genomic sequencing of patient samples provided detailed information of gene mutations in PMF, but the mechanism of myelofibrosis remains largely unknown. Placing ECM center-stage in the study of the pathogenesis of PMF, this project promises to open a second front against PMF that may overcome therapeutic limitations of the current gene-mutation centered approach, will deepen our understanding of how ECM affects blood production in general, and will contribute to understanding of other diseases in which myelofibrosis occurs secondarily, such as leukemias and myelodysplastic syndromes.